Rapid sugar sensing from gut to brain

PROJECT SUMMARY/ABSTRACT
The average American adult consumes over 40 pounds of sugar per year. While sugar intake is necessary for
energy metabolism and survival, this overconsumption has led to rampant obesity and diabetes. Therefore, it is
critical to determine the gut-brain circuit that drives sugar overconsumption. Recently, specialized sensory cells
in the intestinal epithelium, known as neuropod cells, were found to sense intestinal sugars and drive sugar
appetite. Neuropod cells sense sugars using sodium-glucose transporters (SGLTs). Most studies on intestinal
sugar sensing have focused on glucose transport ability itself, but little is known about sensing in the absence
of transport. Here, we will use an anti-diabetic molecule specific to human SGLTs to probe whether it is
glucose transport or sensing that is necessary to activate the neuropod cell sugar sensing circuit. My
hypothesis is that sugar sensing, in the absence of transport, will activate neuropod cells, causing glutamate
release and vagus nerve activity. Therefore, I am pursuing the following aims: 1) to determine whether specific
SGLT activation leads to neuropod cell glutamate release and 2) to determine whether an anti-diabetic
molecule leads to rapid, neuropod cell dependent vagal activity. My approach includes neurogenetic
manipulations of intestinal organoids and in vitro and in vivo electrophysiology. These studies may uncover a
pharmacological target for modulating rapid gut-brain control of food choice without perturbing life-sustaining
sugar absorption. My co-sponsors, Drs. Diego Bohórquez, Ph.D. and David D’Alessio, M.D., are experts in
neuropod cell nutrient sensing and hormone signaling in obesity, respectively. Consistent with their long-
established track record of mentorship, the proposed studies and training plan will provide me with the rigorous
scientific training and leadership skills necessary for a career as a physician-scientist based on gut-brain circuit
manipulation as a bariatric intervention.

Public health relevance
PROJECT NARRATIVE The consequences of sugar overconsumption in America are clear: two-thirds of Americans suffer from diet- related chronic illnesses including obesity and diabetes. Specialized sensory cells in the intestine, called neuropod cells, drive sugar appetite. The proposed studies will define the receptor required for neuropod cell sugar sensing, revealing a novel pharmaceutical target for downregulating sugar appetite.